Breaking Down Bones: Hepato-skeletal crosstalk in MASLD-associated fracture susceptibility

PROJECT SUMMARY/ABSTRACT
Metabolic dysfunction-Associated Steatotic Liver Disease (MASLD, previously Non-Alcoholic Fatty Liver
Disease or NAFLD) affects 30% of people globally. Among these, 1 in 4 have a more severe form of the
disease, Metabolic dysfunction-Associated Steatohepatitis (MASH). MASLD and MASH strongly associate with
high caloric intake and are highly comorbid with obesity, metabolic syndrome, and type II diabetes. The onset
of MASLD is insidious, incurable and it affects a massive proportion of the global population.
Persons with MASLD are at increased risk of osteoporosis and fracture. Given the high prevalence of
MASLD and massive osteoporosis-related healthcare spending, MASLD-associated skeletal fragility exerts
substantial socioeconomic impact. The mechanisms by which skeletal fragility arises in MASLD and MASH are
not understood, owing largely to the lack of an appropriate preclinical model. Most mice do not develop
MASLD from conditions mimicking the human disease. Uniquely, the Diet Induced Animal Model of NAFLD
(DIAMOND) mouse, will develop MASLD and MASH on a high-fat Western diet alone, like humans. The
DIAMOND mouse mimics the human phenotype of MASLD and MASH exceptionally well. Using these mice,
we demonstrated significant deleterious changes in mechanical strength and geometries of bones from
DIAMOND mice fed a high-fat Western diet. In this study, we aim to elaborate histologic bone changes and
liver-bone crosstalk driving skeletal fragility in MASLD and MASH. Further, we will describe the role of estrogen
in the development of MASLD-associated skeletal fragility, and its role in the sexual dimorphism of the liver and
bone phenotype of DIAMOND mice. Finally, we will investigate the skeletal effects of GLP-1 analogs,
extremely popular drugs in MASLD management, in mice with MASLD. In Aim 1, we will conduct a longitudinal
assessment of the progression of skeletal fragility in DIAMOND mice with MASLD. We will assess bone
morphology, biomarkers of bone metabolism, and liver bone crosstalk. These analyses will be correlated with
the progression of MASLD on liver histology. In Aim 2, we will leverage the clinical observation that women are
relatively protected from skeletal sequelae of MASLD to elaborate a protective role of estrogen. We will
ovariectomize female DIAMOND mice to assess the effect of estrogen withdrawal on MASLD-associated
skeletal fragility. We will use the same liver and bone phenotype, serum biomarker, and pathway analyses
described in Aim 1 to assess the role of estrogen withdrawal in the progression of MASLD bone disease. In
Aim 3, we will determine the extent to which GLP-1 analogs rescue bone loss in MASLD via similar outcomes
to Aims 1 and 2. While many observational analyses have recently been conducted on bone disease in
MASLD, this proposal will be the first prospective study to assess its molecular mechanisms. We aim to
discover candidate pathways for novel, effective therapies for this disease.

Public health relevance
PROJECT NARRATIVE Persons with Metabolic dysfunction-Associated Steatotic Liver Disease (MASLD, ~30% of people globally) are at increased risk of skeletal fragility and fracture by an unknown mechanism. We propose to use the DIAMOND mouse, a uniquely well-suited animal model of MASLD development and progression, to identify candidate molecular pathways for further study, investigate the role of estrogen and its role in the sexual dimorphism of MASLD-associated skeletal fragility, and the impact of GLP-1 analogs on MASLD bone disease. The goal of this research is to understand the nature of skeletal fragility in MASLD, its sexual dimorphism, and establish candidate mechanisms by which it arises to enable development of effective treatment strategies.